iPSC Processing Core

PROJECT SUMMARY (CORE B - iPSC Biobank Core):
The Core B serves as a critical pillar in the collective efforts of this Program Project. Its central mission is to
support and empower all projects and cores by providing essential resources, infrastructure, and expertise
focused on induced pluripotent stem cells (iPSCs) and their pivotal role in unraveling the intricacies of
cardiotoxicity associated with cancer therapeutics.